The Memorial Sloan Kettering Cancer Center SPORE in Pancreas Cancer

PROJECT SUMMARY –OVERALL
An increasing number of studies indicate that some patients with pancreas ductal adenocarcinoma (PDAC) have
exceptional and durable responses to therapy, both standard of care and, more rarely to immune-based
therapies. There is a unique opportunity to understand the genetic and molecular mechanisms that underlie
these exceptional responses or define mechanisms of intrinsic resistance to therapy to prospectively guide
clinical management and ultimately increase overall survival for all patients with pancreas cancer. We propose
a Specialized Program of Research Excellence in Pancreas Cancer at Memorial Sloan Kettering Cancer Center
(the MSK Pancreas SPORE) to leverage cutting-edge molecular knowledge of pancreas biology and clinical
innovations to advance translational research in pancreas cancer. Our long-term translational objective is to
demonstrate that prospective, next-generation molecular approaches combined with state-of-the-art clinical
management can improve outcomes of patients with pancreas malignancies. We will specifically focus on the
most challenging disease settings, locally advanced and metastatic PDAC, where the clinical needs are most
profound. To achieve this objective, we propose three specific aims. In Aim 1, we will leverage current state-of-
the-art and novel therapies to improve outcomes for patients with stage III and IV PDAC by building upon recent
developments in cytotoxic and targeted therapies and apply these agents and combinations in novel disease
settings. In Aim 2, we will apply innovation in molecular characterization of PDAC to drive clinical management
by building upon our extensive expertise in imaging, molecular diagnostics, biomarker development, and single-
cell analyses to develop and validate prospective biomarkers of treatment response and resistance. In Aim 3,
we will investigate two avenues of surmounting intrinsic immunotherapy resistance in PDAC: synthetic lethality
of combination PARP inhibition and immune checkpoint blockade, and via activation of the interleukin-33 – group
2 innate lymphoid cell (IL33-ILC2) axis. We expect that successful completion of these aims will provide new
insights into PDAC biology, establish new collaborations, alter treatment paradigms, and ultimately improve
disease-free and overall survival in pancreas cancer.

Public health relevance
NARRATIVE – OVERALL We propose a Specialized Program of Research Excellence in Pancreas Cancer at Memorial Sloan Kettering Cancer Center (MSK Pancreas SPORE). Our goal is to leverage cutting-edge molecular knowledge of pancreas biology combined with clinical innovations to advance translational research and ultimately improve outcomes for patients diagnosed with this disease.